Impaired Vasoreactivity, Sleep Degradation, and Impaired Clearance in the APOE4 Brain

PROJECT SUMMARY/ABSTRACT
The ε4 variant of apolipoprotein E (APOE4) is the strongest and most common genetic risk factor for sporadic
Alzheimer’s disease (AD), which makes up more than 95% of AD cases. APOE4 has been demonstrated to
contribute to a number of molecular processes implicated as promoting AD pathology, including accelerated
aggregation of amyloid-β and tau proteins, increased immunoreactivity, altered lipid metabolism, and impaired
cerebral blood flow, but an over-arching mechanism of the conveyed AD risk remains unclear. As a leading risk
factor for atherosclerosis as well as AD, APOE4 has profound effects on vasculature. Previous studies have
found dysregulated neurovascular coupling, high levels of the vasodilator nitric oxide, and impaired flow of
cerebrospinal fluid around arteries in the brain, suggesting decreased glymphatic clearance, a process that
occurs most dramatically during sleep. Consequently, physiological sleep patterns are also known to be
disrupted in AD, suggesting a common theme in many of the identified APOE4-dysregulated processes. We
propose that altered neurovascular coupling and vasodilation will alter sleep stage patterns and disrupt
sleep, which will impair the clearance of cellular waste products from the brain. Many of these waste
products, such as protein aggregates, inflammatory cytokines, and metabolites can be neurotoxic, and can
create a positive feedback cycle as they in turn affect neural activity and vascular integrity and function, further
disrupting sleep. To test this idea, we will combine the neurobiological and technical expertise of three research
groups studying distinct levels of brain function to perform an integrative, multi-scale study of brain physiology
and function in knock-in mice carrying humanized APOE4 and APOE3. First, we will use custom-developed
hardware for chronic, long-term EEG monitoring of APOE4 and APOE3 mice and specialized machine learning
for real-time characterization of sleep stages to identify shifts in sleep patterns and quality over the course of
aging (3 months to 15 months). Second, we will quantify impairment of cortical vasodilation and vasoreactivity
by conducting 2-photon imaging to measure the diameter of cortical arteries in behaving APOE4 and APOE3
mice, both awake and in natural sleep, at different time points over the course of aging. Third, we will perform
multiplexing and -omics assays of brain tissue from APOE4 and APOE3 mice during day (light) and night (dark)
over the course of aging to quantify the levels of inflammatory cytokines and metabolites. Finally, we will further
test our hypothesis and attempt to ameliorate AD-promoting pathology by introducing exercise as a potent
vasodilator and stimulus of cerebrovascular health. Upon completion of the proposed work, we will have
determined the trajectories of altered sleep stages and quality, impaired vasodilation, and dysregulated
production and clearance of immune and metabolic products in APOE4, and tested the relationship between
these pathologies by introducing exercise from young age to ameliorate vascular dysfunction.

Public health relevance
PROJECT NARRATIVE The ε4 variant of apolipoprotein E (APOE4) is the strongest and most common genetic risk factor for Alzheimer’s disease, but the underlying reason for this risk remains unclear. APOE4 is also a risk factor for heart disease, and is known to cause fatty plaque build-up in blood vessels, as well as impair blood flow. We propose that impaired blood flow and blood vessel movement caused by APOE4 can affect sleep and interfere with the clearance of waste products from the brain, promoting the brain cell death that causes Alzheimer’s disease. To test this idea, we will measure changes in brain blood vessel size, monitor sleep stages and quality, and assess levels of brain inflammation and cellular waste in a mouse carrying the human APOE4 gene. This study will also test the effects of exercise on these processes, and determine whether exercise can correct the overall changes caused by APOE4.